Multimodal Network Connectivity Architecture (MOCA) of the Brain and its Role in the Recovery of Consciousness in Comatose Cardiac Arrest Patients

Project Summary
Cardiovascular disease remains the leading cause of death in the United States. Mortality rates from cardiac
arrest range from 60-85%, and of survivors, up to 80% are initially comatose. Once circulation has been
reestablished, the extent of brain injury is a key factor for prognostication. Poor neurologic prognosis
commonly leads to the withdrawal of life-sustaining therapies (WLST) and subsequent death. According to the
2015 American Heart Association Guidelines, the most reliable strategy for prognostication of poor outcome
remains a key knowledge gap in the treatment of post-cardiac arrest survivors. Traditional recommendations
for neurologic prognostication have proven unreliable in modern studies of cardiac arrest patients. New
techniques with improved accuracy are needed to avoid premature WLST from patients who may ultimately
recover with good neurologic outcome. A large subset of patients initially comatose after cardiac arrest will
have normal neuroimaging and electrophysiology, only to deteriorate in the subsequent days. This likely
represents a therapeutic window prior to the onset progressive ischemia, apoptosis, hypoperfusion and
cerebral edema, which most often leads to poor outcome. We hypothesize that multimodal approaches that
include clinical, electrophysiology, biochemical and MRI data will improve prognostication of short-term and
long-term outcome in initially comatose cardiac arrest patients, helping to identify those most likely to benefit
from therapeutic interventions in the future. We propose to perform a prospective observational study in
cardiac arrest patients still comatose 24 hours post-arrest, or 24 hours post-rewarming in those treated with
targeted temperature management. Our study focuses on patients for whom prognostication is typically most
challenging, and who are most likely to benefit from advanced assessment tools. We will systematically
evaluate whether these tests can predict short-term neurological recovery and ultimately long-term
neurological outcome. Our first aim is to determine whether acute MRI and electrophysiology can identify
which patients are most likely to regain arousal. The benefit of using recovery of arousal as a surrogate marker
for long-term outcome is that it will be less plagued by a self-fulfilling prophecy bias from WLST. Secondarily,
we will investigate whether subacute MRI and EEG assessments are associated with neurological outcomes at
discharge, 3, 6 and 12 months.

Public health relevance
Relevance: Accurate early neurological prognostication in comatose post-cardiac arrest survivors remains challenging, especially in the era of targeted temperature management. Identifying patients at risk for progressive neurological deterioration is crucial, as these are most amenable to intervention with innovative therapeutics. Our study will investigate the neuroanatomical and neurophysiological basis underlying brain injury and recovery in cardiac arrest patients who remain unresponsive greater than 24 hours after resuscitation, in whom accurate methods of long-term neurologic prognostication are currently lacking.